Admin Core TAMU (Sacchettini) Lead

Project Summary – Core C
The TBSGC is a large, multi-institutional program with several different investigators and collaborators.
The goal of Core C is to provide administrative support and program management across the varying
projects and sites.